University of Illinois Veterinary Diagnostic Laboratory participation in Veterinary Laboratory Investigation and Response Network

Title: University of Illinois Veterinary Diagnostic Laboratory participation in Veterinary
Laboratory Investigation and Response Network
Project Abstract
This proposal is to request funding to continuously support the University of Illinois Veterinary Diagnostic
Laboratory (UI VDL) to participate in the Veterinary Laboratory Investigation and Response Network (Vet-LIRN)
program. The UI VDL is a full-service American Association of Veterinary Diagnosticians-accredited state
laboratory and is a member of the National Animal Health Laboratory Network and Vet-LIRN program. The lab
has been in the Vet-LIRN program since 2017 and currently serves as a core source lab for the program. The
lab commits to continuously participate in all Vet-LIRN-directed activities, which includes 1) responding to animal
food or drug-related illnesses, 2) detecting multi-drug resistant bacteria and newly emerging viral pathogens,
and 3) improving and validating diagnostic approaches. The funding will be utilized to maintain equipment and
to purchase the required materials for conducting Vet-LIRN-related projects and research projects in
microbiology. The well-equipped and staffed UI VDL is delighted to fuel our efforts to benefit research in
veterinary science and the goals of One Health.

Public health relevance
Public Heath Relevance Statement: Project Narrative The emergence of multi-drug resistant (MDR) bacterial pathogens and highly zoonotic viruses has greatly threatened animal and human health over the past decades. In this cooperative agreement, the UI VDL is pleased to assist the Vet-LIRN program to 1) respond to complaints in animal food and treats, 2) collect bacterial pathogens and examine their antibiogram to help the program to develop antimicrobial stewardship for veterinary and human medicine practitioners, 3) participate in Vet-LIRN-led proficiency tests and new test development and validation to enhance the accuracy of diagnostic approaches. We expect the participation of the UI VDL will facilitate the Vet-LIRN program to promote animal health and consolidate the veterinary diagnostic network.